CONTROL OF GENE EXPRESSION IN BACTERIOPHAGE LAMBDA

We are continuing our study on the nature of transcription termination in E. coli and of the mechanism of action of the bacteriophage lambda N protein, that suppresses transcription termination. We are constructing two new vector systems. The first of these is designed to clone DNA fragments bearing promoters active in E. coli. The second, a shuttle vector, is tailored for the cloning of large, and/or unstable DNA fragments, as well as for the reconstitution of genes from overlapping DNA clones. We are examining the ability of coliphage P1 to stimulate the precise excision of transposons. The responsible gene has been subcloned, and we are attempting to clarify the molecular mechanism of this reaction. We are studying gene regulation in the temperature colliphage HK022. HK022 antagonizes the action of the LambdaN protein. We are also studying the control of bacteriophage lambda cII activity by phage and host functions.